A Novel Instrument and Consumables for Quality Control in Next Generation Sequencing

ABSTRACT
Sample preparation for next-generation sequencing (NGS), also known as library construction, is a laborious
and lengthy process consisting of numerous complex biochemical operations that require several quality
control (QC) checks to ensure optimal success. Gel electrophoresis utilizing automated instrumentation
remains the standard QC technique for nearly all NGS applications and library workflows, whereby several
nano-grams of DNA at numerous library QC checkpoints is separated by size, visualized via fluorescence and
compared to known standards (DNA ladders) for analysis. With the rapid advancement of NGS technologies
and library preparation chemistries, gel electrophoresis has fallen behind the critical market needs of cost
reduction, faster analysis time, lower sample input (sensitivity), reduced complexity of kits and cold chain
reagents, sample structural information, and sizing resolution of large DNA. Evizia has developed PRECYSE,
a biomolecule desktop imaging system based on High-Speed Atomic Force Microscopy (HSAFM), through
combining expertise across physics, chemistry, genomics and software analytics. A user replaceable AFM
probe scans an atomically flat consumable surface containing up to 96 separate DNA samples to generate a
topographical image down to single molecule nanometer resolution. Onboard software instantaneously
analyses complex biomolecule mixtures to generate vastly improved QC metric specificity and sensitivity.
Specific capabilities include sizing of DNA from 100 bp to 250 kb+ in minutes, consolidation of QC to a single
inexpensive consumable chip without cold chain reagents, <25 pico-grams of input DNA, and the unique
capability of directly visualizing structural information; bound proteins, DNA secondary structure, or library
contaminants. Initial customer collaborations showed numerous structural DNA phenomena undetectable by
electrophoresis that could directly impact sequencing throughput and read quality. Evizia aims to refine
consumable production, further optimize key instrument components for further cost reduction and continue
expanding customer NGS collaborations. PRECYSE will redefine how NGS QC is performed today for all
customer archetypes. In exceeding NGS QC market demands Evizia hopes to contribute to the rapid
expansion of NIH funded NGS programs looking to advance our understanding of the human genome and
develop personalized medicine.

Public health relevance
NIH Project Narrative Evizia, Inc. Evizia developed an instrument which visualizes and measures single molecules. The company’s objective is to support researchers and clinicians who are urgently pushing the bounds of discovery in genomics and precision medicine. The instrument aims to replace old, technologically inferior and expensive processes with a platform that is lower cost, preserves precious patient samples and provides higher quality information.